The Toxoplasma basal complex in cell division

Summary
Toxoplasma gondii is an obligate intracellular apicomplexan parasite causing severe opportunistic infections.
Current drugs are prone to induce hypersensitivity, especially upon long-term use. Under this proposal the
unique cell division process will be interrogated to identify putative new drug targets. Toxoplasma divides by a
distinct internal budding process whereby two daughter parasites are assembled within a mother cell. The
cortical membrane skeleton composed of flattened alveolar vesicles supported by an epiplastin protein network
and 22 subpellicular microtubules (MTs) is nucleated on the centrosomes and assembles in an apical to basal
direction. In the second half of division the posterior end of the daughter buds (i.e. the basal complex or BC)
starts to taper driven by Myosin J (MyoJ). Absence of MyoJ only modestly impact parasite viability, even while it
leaves the BC somewhat unconstricted, fitting classic data on cell division resistance to actin depolymerizing
agents. However, preventing assembly of the BC altogether by depleting or overexpressing the BC scaffolding
protein MORN1 results in parasites with fraying MTs unable to complete cell division and has dramatic impact
on viability. To unravel this intriguing process, under an R21 grant the BC was proteomically dissected through
proximity dependent biotinylation (BioID) on 8 BC components. This revealed 4-5 different protein complexes
aligning with the ultrastructure. Two key observations are further pursued under this proposal: 1. A putative MT
Associated Protein, MAP1B-L1, appears to assemble on the (+)-ends of the subpellicular MTs and is essential
for BC assembly and parasite viability; 2. Several kinases and phosphatases identified indicate the BC is
regulated by differential phosphorylation. Under Aim 1 MAP1B-L1 and another critical BC MAP dubbed MAP1B-
L2 will be tested for MT binding capacity by generating deletion mutants in the parasite, in vitro using the
identified MT binding domains, and by exogenous expression in the Xenopus leavis axon guidance model as
relevant to related MAPs. Under Aim 2 we will pursue four additional candidates identified in the BioID approach
with a likely essential function, which are all hypothetical proteins narrowly conserved in internally budding
parasites and harbor putative adhesion domains. In addition, we will apply fast acting TurboID on BC components
transiently associating with the assembling BC like MAP1B-L1 as these were likely undersampled in the current
dataset, yet define the essential step of the BC in cell division. Under Aim 3 we will subject 2 kinases and 1
phosphatase to synthetic lethality screening using the genome wide CRISRP/Cas9 library. Preliminary data of
the first kinase tested already demonstrates experimental feasibility and revealed interesting new insights.
Combining the proteomic and genetic data sets is expected to provide a solid basis to assemble the wiring
diagram of the BC. In the current working model the BC is first assembled on the MT (+)-ends, followed by
recruitment of adhesion proteins to keep the MT-ends together. Overall, this is expected to deliver exciting new
insights into internal budding, how it differs from schizogony, and could highlight new drug targets.

Public health relevance
Narrative The protozoan Toxoplasma gondii in an opportunistic parasite causing encephalitis and birth defects, and is the number two most lethal food-borne infection in the USA. In order to identify additional drug targets to increase the limited treatment options, the cell division machinery will be dissected under this proposal. Specific goral is understanding the assembly and regulation of the ring responsible for separating the two daughter parasites to complete division.